sTMS for Substance Use-disordered Veterans

The goal of this proposal is to evaluate preliminary participant response to a pilot, controlled,
feasibility study to evaluate changes in craving, substance use, and quality of life after 6 weeks
of a low-risk non-invasive brain stimulation technique, called Synchronized Transcranial
Magnetic Stimulation (sTMS), compared to sham, in Veterans with a substance use disorder
(SUD). An important focus of this application will be evaluating the acceptability, tolerability, and
safety of sTMS in this population. To our knowledge, sTMS has never been used for SUDs, and
holds considerable promise as a future treatment option for these prevalent disorders. However
initial work in the acceptability, tolerability, and safety of this approach must be conducted first.
This project is the first step towards our long-term goal, which is to combine non-invasive brain
stimulation with individualized psychotherapy or pharmacotherapy to reduce SUD problems and
improve quality of life for Veterans.

Public health relevance
Addiction continues to be a serious problem among Veterans and more treatment options are required. Promising new evidence suggests that stimulating the brain using electricity may be a new approach to treating mental health issues including addiction, but brain changes specific to some forms of addiction may limit the utility of this approach. A related approach of stimulating brain circuits using magnets may yield similar results and circumvent the addiction-specific issues. This project aims to test the feasibility and acceptability of synchronized Transcranial Magnetic Stimulation as a treatment for substance use disorders.